Training

The Training Component of the Patient-centered Information Commons or PIC has chosen to focus on three major elements that will rely (1) on the strength of this team's existing infrastructure at the Center for Biomedical Informatics at Harvard Medical School and (2) the new science proposed for the Data Science Research component of this proposal to support the overall goals of the Big Data to Knowledge initiative. Direct training of the next generation of leaders is offered in two forms, a pre-doctoral-level distributed training initiative and an undergraduate research internship. With the goal of attracting students to the field of big data science, the competitive Distributed Pre-doctoral Program will target students currently enrolled in quantitatively-focused graduate programs across the country who have passed their qualifying exams and would like to engage in a distance collaborative project with faculty at PIC, thereby exposing them to opportunities not available at their local schools. The undergraduate research internship (Summer Institute in Bioinformatics and Integrative Genomics) will offer a nine week, intensive immersion in didactic lectures with leading big data scientists and a mentored research project with PIC faculty. A second major element will develop a series of instructional Big Data videos that will be publically available to the community. Choice of topics will be developed in consultation with the Consortium members. Lastly, the PIC training and science teams will host both an annual Big Data Conference and a series of monthly Lectures which will be available to the community via videography (for the Conference) and WebEx (for the Lecture series). Success of these initiatives will be evaluated by a defined set of metrics, including surveys and outcomes assessment.

Public health relevance
Insuring the next generation of scientists capable of understanding and applying the cutting edge technologies necessary to the acquisition and management of the increasingly huge volumes of data enabled by technology advancement that has exceeded our ability to fully utilize its byproducts is essential to the rapid advancement of biomedical research in general and "precision medicine" in particular.